Understanding the relationship between sleep, motor learning, and motor development in early childhood

PROJECT SUMMARY
Early childhood is a period of neuroplasticity and change across physiological, cognitive, and behavioral
domains. Interactions among domains abound and cumulatively support future health outcomes. The present
fellowship hones in on the relationship between sleep and motor development. Research with adults supports
the impact of specific sleep features (e.g., spindles and slow oscillations) on motor memory consolidation. As
such, the central hypothesis of the present work is that sleep oscillations support motor learning in early
childhood and that maturational changes in these sleep features support motor development. Specifically, the
research aims to identify sleep EEG markers that predict motor memory consolidation (Aim 1) and motor
development (Aim 2). To address Aim 1, 4-year-old children (48-52 months) will participate in a within and
between subjects design that will ensure rigorous investigation while controlling for individual differences. They
will learn the mirror-tracing task at either 7AM or 7PM and performance will be tested 12- and 24-hrs later
following an interval with sleep (7PM-7AM) and wake (7AM-7PM; within-subject, order counterbalanced).
Overnight sleep bouts will be recorded with polysomnography (sleep EEG) and a unique behavioral coding
schema, microgenetic coding, will be used to measure mirror-tracing performance in addition to traditional
measures. To address Aim 2, I will use data from a longitudinal R01 of the sponsor in which 3-4-year-old
children’s sleep is assessed every 6 months for 1 year. At each timepoint, they will complete a standardized
motor assessment (Movement Assessment Battery for Children III) and overnight sleep will be recorded. Sleep
physiology (sleep oscillation coupling and topography) are hypothesized to predict motor learning (Aim 1) and
motor development (Aim 2). The aims of the proposal have public health significance in that they will identify
potential windows of opportunity to intervene on health behaviors (i.e., good sleep habits), learning, and motoric
ability at a critical developmental period of the lifespan. The findings can inform future intervention studies,
particularly in collaboration with physical and occupational therapists, as well as early childhood education
policies and considerations for pediatricians. Collectively, the proposed development plan incorporates activities
for training in cognitive neuroscience, sleep, coding and machine learning, statistical analyses, and grant writing.
Successful completion of this proposed training plan will result in several submissions of first-author manuscripts
to peer-reviewed journals and will establish an essential research foundation to support a competitive early
career funding proposal. The fellowship will provide protected time and unique cross-disciplinary training for
successful completion of outlined goals.

Public health relevance
PROJECT NARRATIVE The acute and chronic impact of sleep on motor learning and motor development in early childhood is foundational for long-term health and behavioral outcomes and may be a target for intervention, but no studies have yet examined their interaction through a cohesive framework. The proposed research is tailored to serve as the initial stepping stone, bridging this gap through dual aims of studying the relationship experimentally and longitudinally. The accompanying training plan will prepare me to forge my independent line of inquiry, expanding the study of sleep, motor learning, and motor development to younger populations, and build on its implications including future intervention studies and early childhood education policies.